RESOURCE-BASED CENTER FOR THE ADVANCEMENT OF PRECISION MEDICINE IN RHEUMATOLOGY

PROJECT SUMMARY/ABSTRACT
PREMIER, the UCSF Precision Medicine in Rheumatology Center (P30), provides critically important
resources and expertise to enable cutting-edge research to advance precision medicine in the rheumatic
diseases. PREMIER brings together clinical expertise, defined patient cohorts, state-of-the-art
immunophenotyping and genomic technologies with experts in bioinformatics and integrative analyses. This
infrastructure facilitates collaborative studies that can integrate the large amounts of clinical and molecular data
needed to gain a more fundamental understanding of the biology driving the heterogeneity of clinical phenotypes
and treatment responses among individuals with rheumatic disease. PREMIER seeks to lower the barriers to
pursuing rheumatology research by providing access to relevant resources along with the expertise to use them
appropriately.
Our Center includes three Resource Cores that will each provide consultation to guide investigators in study
design, analysis, and access to significant expertise and assistance in forming the collaborations needed. The
Clinical Data and Informatics Core (CDI), directed by Dr. Jinoos Yazdany, will provide clinical research and
informatics services including access to large rheumatic diseases databases, biospecimens and curation of
electronic health record data for research discovery; the Genomic Technology Core (GT), co-directed by Drs.
Jimmie Ye and Walter Eckalbar, will develop novel genomic technologies and institute specialized workflows
and analytic pathways designed for the study of rheumatic diseases; and the Integrative Bioinformatics Core
(IB), co-directed by Drs. Marina Sirota and Gabriela Fragiadakis, will address investigator needs for advanced
bioinformatics expertise, particularly with regard to single cell analytics, multi-omic integrative analysis, and use
of publicly available data. PREMIER’s Administrative Core is led by Dr. Mary Nakamura (Director) and Dr.
Jinoos Yazdany (Associate Director) and provides leadership and organizational oversight to the Center. The
Core includes a significant enrichment program involving seminars, an annual symposium, workshops led by the
Resource Cores, a mentoring program, and a grant program including Development and Feasibility Pilot grants
and Core Usage Grants. PREMIER leverages a number of significant UCSF and divisional resources that are
highly synergistic with the services offered in PREMIER Resource Cores.
Given our track record and deep commitment to innovation, PREMIER is poised to attract new
investigators and further advance rheumatology research towards the ultimate goal of improving
diagnosis and treatment of rheumatic disease through the detailed elucidation of underlying disease
mechanisms.

Public health relevance
PROJECT NARRATIVE PREMIER, the Precision Medicine in Rheumatology Center at UCSF will provide investigators with access to resources, expertise, training and pilot funding to capitalize on new technologies and opportunities in precision medicine. PREMIER will support innovative, collaborative studies to better define rheumatic disease subgroups that may have different etiologies, prognosis, or treatment responses. By providing Core resources in clinical research and informatics, state-of-the-art single cell molecular phenotyping and transcriptomics, and integrative bioinformatics analysis, PREMIER will advance studies of clinically phenotyped patient samples to improve diagnostic and treatment approaches to rheumatic disease.